DP21-001 Florida Pregnancy Risk Assessment Monitoring System

Project Summary/Abstract
The Florida Department of Health, Division of Community Health Promotion along with
state partners understand the need to collect, analyze, and disseminate population-
based data on maternal and child health indicators (MCH) of high scientific quality. The
purpose of the Florida Pregnancy Risk Assessment Monitoring System (PRAMS)
project is to conduct surveillance of select maternal behaviors and experiences before,
during, and shortly after pregnancy from women in the state of Florida who recently
experienced a live birth. Their response to the survey will afford Florida the opportunity
to improve resources, health care, and programs available to women and children
across the state.
Objectives and specific aims of Florida PRAMS are to: (1) collect population-based data
of high scientific quality on topics relative to pregnancy and early infancy; (2) perform
data analysis in efforts to increase understanding of maternal behaviors and
experiences during pregnancy and early infancy, and their relationship to health
outcomes; (3) translate results from analyses to useable information for planning and
evaluation of public health programs and policy; and (4) build high functioning state
capacity that will allow transparency and sharing of data analyses findings.
To achieve specific aims of PRAMS, Florida PRAMS intends to ensure that data
collection activities align with the Centers for Disease Control and Prevention (CDC)
PRAMS protocol by administering surveys to the sample population via US mail and
follow-up of non-responders by telephone. Inclusion of a sample population that will
transcribe into data analyses will be the foundation of understanding and guiding state
and CDC PRAMS MCH issues, programs, and resources.
Collection of PRAMS data will ensure that Florida PRAMS can benchmark and measure
State Maternal and Child Health Priorities such as, reduce infant mortality and related
disparities, prevent pregnancy-related mortality and maternal morbidity, and reduce
racial disparities. To conclude, Florida PRAMS will continue to engage and collaborate
with state and local partners, and data users to address state-specific needs which align
with PRAMS goals.

Public health relevance
Project Narrative It is important to monitor factors that contribute to the health of mothers and their infants. The proposed research project, Florida Pregnancy Risk Assessment Monitoring System (PRAMS), seeks to collect valuable information about specific maternal and child health (MCH) issues that can only be achieved through the collection and utilization of population-based MCH data. Objectives include collecting PRAMS data to assess factors that contribute to infant mortality, improve prenatal care for expecting mothers, and strengthen programs to improve the health of women and children within Florida.